Kidney single cell and spatial molecular atlas project - KIDSSMAP

$EVWUDFW &RUH
The KIDney Single cell and Spatial Molecular Atlas Project (KIDSSMAP) aims to generate an extensive
spatially resolved 3D atlas of human kidney. This involves generation of high-resolution data capturing different
classes of molecular moieties: from RNA and chromatin accessibility, to proteins, lipids and metabolites. These
molecular facets will be assessed by a suite of different experimental techniques, applied to 3D tissue blocks,
2D sections, or dissociated cell suspensions. The central goal of the KIDney Data Analysis Core (KIDDAC) will
be to integrate these data across different scales, molecular modalities, and a diverse set of individual
characteristics (sex, age, race). This will be done on both the level of cellular and microanatomical structure
annotation. KIDDAC will also coordinate uniform pre-processing and quality control (QC) of the individual
modalities. Finally, production of a comprehensive tissue atlas will also require effective computational
infrastructure for tracking of individual samples, execution of primary analysis pipelines, as well as automated
submission and sharing of data with the HIVE/HuBMAP consortium and wider scientific community. The
resulting atlas will illuminate principles underlying the complex microanatomical organization of the kidney and
will provide a much-needed integrated baseline for characterizing aberrant states of the cells or tissue that
might arise during disease.